Novel Roles of Placental Allopregnanolone in Brain Development and Injury

ABSTRACT
Compromised placental function is highly associated with abnormal fetal brain development, and later with
neurodevelopmental disorders such as autism, epilepsy, and schizophrenia, but the causal mechanisms
remain largely unknown. The prevalence of these neurodevelopmental disorders is increased in those born
preterm or born after pregnancies with evidence of poor placental function. Altered cortical GABAergic signaling
has been implicated in many neurodevelopmental disorders, but until recently the tools to examine the
relationship between placental dysfunction, altered cortical development and GABAergic signaling did
not exist. In the initial funding period of this proposal, we validated and used our novel mouse model to
directly demonstrate for the first time that a key placental hormone-- allopregnanolone (ALLO)-- is needed
for normal brain development and that its loss contributes to long-term neurological dysfunction. ALLO is a
potent GABAergic neurosteroid derived from progesterone that is made predominantly by the placenta in
both rodent and human late gestation, resulting in high fetal brain concentrations of placentally-derived
ALLO. Deleting the gene encoding the ALLO synthesis enzyme only from the placenta resulted in decrease in
gestational ALLO exposure and produced global, yet sex-linked and regionally-specific, changes
neuroanatomy and behavior. Reduced placental ALLO production impaired prenatal somatosensory
corticogenesis and upper layer pyramidal neurons were permanently decreased, predominantly in female
offspring, who also showed impaired somatosensory behavior. Molecular analyses of human postmortem
brain specimens suggested similarities between mouse placental ALLO insufficiency and human preterm
cortical development. Building on these published findings and on preliminary data showing that placental
ALLO loss is associated with decreased cortical GABAergic interneuron density, altered GABA system-related
gene expression, and changes in spontaneous inhibitory post-synaptic currents in mouse somatosensory cortex,
we propose a new series of experiments in our mouse model to test the hypotheses that placental ALLO
loss (1) disrupts the production and survival of specific cortical interneuron subclasses and (2) permanently
alters the cortical excitation/inhibition (E/I) balance. We will then extend our analysis using our recently
established in vitro brain organoid system to (3) define dosage and timing of ALLO exposure and withdrawal
across multiple stages of human cortical interneuron development. Together, these next studies will
elucidate new mechanisms by which placental hormones, including ALLO, can shape GABAergic cortical
development. This work is starting to fundamentally change our understanding of developmental brain disorders
and the placenta’s role in shaping long-term neurological outcomes and moves us closer to use of novel
therapies based on placental hormones to prevent or ameliorate neurodevelopmental impairments.

Public health relevance
NARRATIVE/PUBLIC HEALTH RELEVANCE Altered exposure to specific placental hormones may underlie diverse neurological disorders including epilepsy, autism, or cognitive deficits. Placental hormone alterations can occur insidiously due to preeclampsia or infection (conditions seen in 5 to 10% of term pregnancies) or acutely due to preterm delivery (representing more than 10% of all US pregnancies); this loss of placental hormone exposure may place many infants at risk of impaired neurodevelopment. Our investigations in neuroplacentology, focused here on allopregnanolone—a potent neuroactive steroid made by the placenta—are important in determining how placental hormones or related compounds can provide novel treatments to ameliorate developmental brain damage due to placental dysfunction.